Understanding Neurocognition in Youth with Type 1 Diabetes (UNYT1D) Biostatistics Research Center (BRC)

Summary
Type I diabetes (T1D) is one of the most common chronic diseases in childhood. Sequelae of pediatric T1D
include neurocognitive dysfunction in attention, psychomotor speed, mental efficiency, visual-motor skills,
memory, and learning possibly due to damage to posterior white matter tracts and associated gray matter
regions. Emerging evidence suggests that diabetic ketoacidosis at time of diagnosis, glucose control, diabetes
device use, sleep, and caregiver distress may be important factors that influence neurocognitive development.
However, there is minimal data in this area and existing studies are limited by small sample size, short
follow-up time, and a lack of diversity in patient populations. A contemporary, adequately powered longitudinal
study in a diverse cohort of prepubescent children is needed to understand the mechanisms associated with
neurocognitive perturbations, critical periods for prevention and intervention, and strategies to mitigate the risk
of neurocognitive complications in later life.
Our research team is uniquely qualified to serve as the Biostatistics Research Center (BRC) for the
Understanding Neurocognition in Youth with Type 1 Diabetes (UNYT1D) nation-wide consortium combining
extensive experience in the coordination of multi-site clinical studies and research networks, biostatistics
expertise in the analysis of complex observational data, and expertise in T1D, glucose variability,
neurocognition, and neuroimaging. Our application leverages the existing infrastructure of the University of
Minnesota’s Coordinating Centers for Biometric Research (CCBR), which has internationally recognized
expertise in coordinating complex, large-scale, multi-site studies and networks and over 50 years of experience
These substantial strengths enable the BRC to accomplish the following specific aims:1) Partner with NIDDK to
provide scientific leadership in the design of a longitudinal cohort study to characterize the neurocognitive
impact of new onset T1D in pre-pubertal children; 2) Provide overall coordination of the national multisite
consortium in the planning and implementation of and adherence to the protocol; 3) Provide consortium-wide
resources for data harmonization, pipelines, management and sharing; 4) Provide expertise in all aspects of
study reporting, data analysis and dissemination.
The BRC will play a crucial role in the success of the consortium. Our research team has a proven
track-record of high-impact research in the clinical management of T1D, a history of developing novel
approaches to neuroimaging data acquisition and analysis, and extensive experience coordinating the
activities of and providing statistical and data management support for multi-site clinical studies and research
networks. Leveraging this experience and capitalizing on the existing infrastructure of the CCBR, we are
uniquely suited to serve as the BRC and support high-quality, robust, and reproducible research through the
UNYT1D consortium.

Public health relevance
Project Narrative The Understanding Neurocognition in Youth with Type 1 Diabetes (UNYT1D) multi-institution clinical consortium will develop and implement a uniform protocol to investigate the neurocognitive impact of new onset type 1 diabetes (T1D) in pre-pubertal children. Our Biostatistics Research Center for UNYT1D will provide scientific leadership for the consortium and consortium-wide infrastructure related to stakeholder engagement, data management and sharing, study design and statistical analysis, and governance and coordination of consortium activities. By combining these activities into a single hub, the BRC will promote rigorous and reproducible research across the consortium and help UNYT1D achieve its scientific objectives.